HUMAN DENDRITIC CELLS AND CHEMOKINES TO ENHANCE IMMUNE RESPONSE TO CANCER

The purpose of this project application is to bring together adoptive immunotherapy, gene transfer, dendritic cell (DC) isolation and use, and chemokine biology to develop a novel vaccine strategy against solid tumors through the combined use of autologous tumor-pulsed DC and chemokine-secreting gene-modified fibroblasts.